A matter of scale: Within-host and between-host processes driving coevolution with parasites

Project Summary
Understanding host-parasite coevolution is intrinsically a multi-scale biological problem. This is
because host immune systems and the parasites/pathogens that challenge them operate on
multiple biological scales. On the molecular scale, host molecules such as the Major
Histocompatibility Complex and Toll Like Receptors bind parasite ligands and thereby aid host
detection of parasites in the body. On the cellular scale, such detection activates proliferation
and differentiation that alters effector function. On the organismal scale, hosts will either live or
die, clear or tolerate infections, depending upon the type and magnitude of immune response
induced by infection. And on the population scale, the survival and reproduction (and hence the
evolutionary fitness) of hosts depend upon how well the host combats infection, while the
transmission (and hence the evolutionary fitness) of parasites depends in large part upon how
well the parasites evade host defenses.
Studying host-parasite coevolution is challenging, not least because of the multiple biological
scales at play. Coevolutionary discovery requires that immunologists (who focus mostly on
within-host processes) connect and collaborate with epidemiologists (who focus mostly on
between-host/transmission processes). Research innovation requires that theoreticians (whose
mathematical models propose how within-host processes might drive between-host processes)
connect and collaborate with experimentalists (whose experimental models allow tests of within-
host and/or between-host hypotheses). The upcoming Jacques Monod Conference on host-
parasite coevolution, to be held in Roscoff, France, in October 2023, will foster such exchanges.
The conference – and coevolutionary discovery more generally – would benefit hugely from the
exchange of ideas, hypotheses, methods, and synthesis amongst a diverse group of scientists
reflecting human diversity. We propose to selectively support travel and subsistence of trainees
(postdoctoral scholars and graduate students) representing backgrounds that have been
historically marginalized. This proposal would foster their participation in an especially
interactive, productive, and generative international conference in host-parasite coevolution.

Public health relevance
Narrative Host-parasite coevolution shapes the amount and type of immune heterogeneity exhibited by hosts as well as the virulence heterogeneity exhibited by parasites. Discovery of the processes of coevolution requires that hosts and parasites are studied at multiple biological scales: from molecules and cells through to the organismal and population scales. To facilitate such research, we are hosting a conference that will empower scientists of all backgrounds, career stages, and research foci to exchange ideas and facilitate new insights into coevolution.